MOLECULAR TOXICOLOGY WORKING GROUP

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. A collaborative project focused on toxicology. The goal of the project is to develop a multiple PI and organization proposal to submit for NIH funding through the RO1 grant mechanism within the next year. The application has been submitted in the February 2008 grant cycle.